Co-Infection: A Global Challenge for Disease Control

DESCRIPTION (provided by the applicant): Support is requested for a Keystone Symposia meeting entitled Co-Infection: A Global Challenge for Disease Control, organized by Rodrigo Corrêa-Oliveira, David Dunne and Andrea Graham. The meeting will be held in Ouro Preto, Brazil from March 15-20, 2015. Multi-species co-infections impose one of the greatest challenges to global health and to our efforts to develop effective methods of infectious disease control. Populations living in rural areas of many low-income countries are exposed to both chronic and acute infection with multiple pathogens. In such conditions co-infection is common and the cause of additive or synergistic morbidities. Studying co-infections is difficult and complex as different pathogens may interact in many different ways, either directly or via the host immune response. Indeed, in some contexts, a community of organisms within a host may promote defense against other organisms. This Keystone Symposia meeting will focus on our current understanding of synergism/antagonism among pathogens causing common co-infections. In doing so it will bring together leading researchers and their knowledge of immune responses in co-infected individuals, co-infection immunoepidemiology, modeling of co-infections to predict disease and infection outcomes, and the specific challenges that co-infection presents to vaccine design strategies, and effective application of chemotherapy. This diversity of scientific disciplines will together address the impacts of co-infection, particularlyin the context of the neglected tropical diseases that are prevalent in many low- and middle-income countries. For example, in some of the poorest parts of the world, HIV, TB, leprosy, HTLV, malaria, dengue, and chronic helminth infections are co-endemic. To find the understanding and the means to effectively tackle the diverse clinical and public health problems of co-infection, we need to combine information derived from basic hypothesis-lead research, descriptive epidemiology and new computational modeling techniques. The goal of this symposium will be to broaden and deepen our understanding of within-host and population-level interactions between different co-infecting pathogens and propose appropriate to move towards clinical and public health solutions, including the delivery of effective vaccination and chemotherapy.

Public health relevance
PUBLIC HEALTH RELEVANCE: Infectious diseases are among the most important causes of childhood mortality and population morbidity in the developing world. Although single infections can be responsible for important levels of mortality and morbidity co-infection also play major role in disease outcome. In this context it is known that co-infection is ubiquitous in people in te developing world but little is known regarding the potential for one pathogen to act as a risk factor for another. The Keystone Symposia meeting on Co-Infection: A Global Challenge for Disease Control will provide a multidisciplinary forum that will focus on disease outcomes, impacts on treatment strategies, the development of new vaccines and the role of modeling in improving our understanding of synergism/antagonism between common co-infecting pathogens.